SDSU FUERTE: Recognition of Excellence in DEIA and Mentorship in support of Faculty Success

OVERALL – Project Summary
San Diego State University (SDSU) is proposing a new program called SDSU FUERTE or Faculty Unified
towards Excellence in Research and Transformational Engagement. The goal of SDSU FUERTE is to recruit a
diverse, nine-person cohort of early career of health sciences faculty focused on Latinx health disparities who
will join SDSU in the 2022-2023 academic year. The recruitment of this SDSU FUERTE Faculty Cohort will be
organized around a prioritized cluster design where emerging scholars eligible for tenure-track positions with
committed research interests in Latinx health disparities and developing expertise in community-engaged
research and implementation science will be asked to expand SDSU’s scholarship in the following areas:
Addiction Science, Environmental Health, and Obesity/Physical Activity/Nutrition. To promote a culture of
inclusive excellence, the SDSU FUERTE leadership aims to support the success of the Faculty Cohort by
removing barriers of isolation and discrimination often experienced by underrepresented minority (URM) faculty
and promoting significant, sustainable change within the university that will support and align multiple
institutional goals — excel the growth in faculty diversity; establish an evidence-based faculty development
plan to accelerate the Faculty Cohort’s research independence; facilitate promotion and tenure and overall
retention among URM faculty; expand SDSU’s research capabilities, capacities, and peer-reviewed funding
portfolio; and ultimately improve the health and wellbeing of the surrounding Latinx communities through the
efforts of SDSU FUERTE’s research. Guided by a new Faculty Development Model, SDSU FUERTE will
implement a comprehensive Faculty Development Plan, composed of a new multi-perspective mentoring team
approach along with mentoring training and a new centralized Core Curriculum that applies evidence-based
strategies to accelerate the research and professional advancement success of its faculty. Three Cores — an
Administrative Core, Faculty Development Core, and Evaluation Core — will be led by an interdisciplinary team
of SDSU leadership who will work collaboratively to implement, evaluate, and refine multiple new strategies to
transform the SDSU community into one that will be nationally recognized as an exemplar in research and
inclusive excellence. Through the resources and national guidance provided by this U54 Faculty Institutional
Recruitment for Sustainable Transformation Program and the significant institutional commitment by SDSU,
SDSU FUERTE is poised to grow and sustain a long-term assurance to valuing diversity, equity, and inclusion,
and ultimately positioning SDSU to build on its Hispanic-Serving Institution designation to become a leading
Research 1 university.

Public health relevance
OVERALL – Project Narrative San Diego State University (SDSU) is proposing a new faculty recruitment and retention program called SDSU FUERTE (Faculty Unified towards Excellence in Research and Transformational Engagement). Utilizing innovative, evidence-based strategies to promote institutional inclusive excellence, SDSU will recruit nine early-stage, interdisciplinary, tenure-track researchers who have career goals to address Latinx health disparities in the areas of Addiction Science, Environment Health, and Obesity/Physical Activity/Nutrition.